Streamlining Microscopy Assay Development: A Comprehensive Workflow Solution for Enhanced Reproducibility and Efficiency

Project Summary
Microscopy users have widely varying levels of expertise and operate in the design and execution of high
complexity assays. Microscopy assay design can be highly challenging due to several key factors including a
growing number of reagents to select from (including functional dyes, fluorophores and primary/secondary
antibodies), significant variety in instrument components and configurations, and increased experimental
complexity with increasing numbers of markers/labels/dyes being included in each experiment (a movement to
multiplex experiments). For many researchers, these requirements can be a barrier to entry and an incomplete
understanding or poor execution can result in improper assay design, poor experimental outcomes, wasted
resources (including rare or low-volume resources), and poor reproducibility. Novel approaches that support
researchers of all skill levels (including early stage through expert scientists) to design better experiments and
select instrument components and reagents that work together has significant potential to reduce costs
associated with wasted resources, improve experimental outcomes, and potentially address one aspect of the
reproducibility crisis. To address this unmet need, FluoroFinder LLC is advancing a novel microscopy workflow
tool to streamline assay development, improve awareness and education around optimal selection of assay
components (instruments and reagents), and improve reproducibility in the field. The FluoroFinder Microscopy
tool is a software-based solution to guide users through a structured workflow that addresses the most common
challenges in microscopy including optimizing microscope component configuration and selecting validated
reagents that are appropriate for a specific instrumental configuration and biological experiment. This will enable
users to identify optimal antibodies, fluorophores, functional dyes, and ancillary reagents for their biological
experiment and instrument set-up. Prior to this Phase I proposal, FluoroFinder has built an extensive database
of fluorescent reagents and antibodies that includes more than 3 million entities aggregated from vendor
databases that are relevant to microscopy applications. Building on the success of a previously developed
industry-leading automated flow cytometry panel builder tool (IntelliPanel), FluoroFinder has initiated
development of a user interface (UI)/user experience (UX) that enables matching of fluorophores to
primary/secondary antibodies for use in microscopy. The goal of this Phase I project is to develop and
demonstrate feasibility for the FluoroFinder Microscopy Tool, where FluoroFinder will complete prototype
development of the UI/UX that supports microscopy experimental design with a guided process that includes
instrument configuration settings and reagent selection. The UI/UX will include support for epi-fluorescent and
confocal microscopy design, as well as cyclic immunofluorescence (CycIF) that supports the latest spatial biology
instruments and methods. Commercialization of the Microscopy Tool would significantly impact research and
medical diagnostics, enabling researchers of all skill levels to identify optimal reagents for their experiments.

Public health relevance
Project Narrative There is a need to develop novel approaches to streamline workflows in fluorescent microscopy to reduce the time to develop assays, increase reliability of results from users across all experience levels, and improve reproducibility. In this project, FluoroFinder is developing a Microscopy Workflow Tool that enables researchers to identify the best method for their biological question by guiding users through a structured workflow, while addressing common challenges including instrument component configuration, selection of validated antibodies and fluorescent reagents, along with recommendations of ancillary reagents that should be considered. Success with these goals would significantly impact research and the diagnostic industry by reducing costs, improving standardization, and improving reproducibility.